Scientific Consulting Group Contract No.: HHSN26120140011I Task order #59

This Scientific Consulting Group Task Order supplies support to the NCI DCCPS Office of the Director, as detailed in the SOW.